Advancing the Future of FDA's Integrated Food Safety System Training

Project Summary
The U.S. retail food regulatory workforce is navigating a period of significant transition, driven by
high turnover, a narrowing pipeline of new professionals, evolving technologies, and rising
expectations for consistent, high-quality training. In response, the FDA’s Office of Training,
Education, and Development (OTED) has established a foundation for a national Integrated Food
Safety System (IFSS) that is competency-based, performance-driven, and grounded in real-world
regulatory practice. The National Environmental Health Association (NEHA) proposes to build on
this foundation by delivering a modern, sustainable training system that expands the reach, quality,
and long-term value of FDA’s investment.
NEHA will continue to collaborate with FDA and Content Advisory Groups (CAGs) to review and
update FDA-aligned courses using instructional systems design principles and SMART learning
objectives. Updates will reflect emerging public health priorities, regulatory changes, and adult
learning best practices to ensure content remains relevant and impactful.
Annually, NEHA will deliver more than 25 FDA-aligned courses through instructor-led, virtual, and
hybrid formats. Each course will be supported by full-service logistics, including instructor
coordination, LMS integration, technical facilitation, and post-course evaluation, ensuring
consistency and accessibility across all sessions.
To enhance reach and sustainability, NEHA will recruit and onboard qualified instructors, provide
mentorship, and conduct ongoing performance evaluations while also strengthening the
Partnership for Regulatory Education and Training (PRET), enabling SLTT professionals to
deliver FDA courses within their local jurisdictions.
NEHA will also implement longitudinal retention studies to evaluate how training translates to real-
world application. Insights will inform targeted follow-up modules that reinforce learning, improve
performance, and strengthen the SLTT regulatory workforce.
NEHA’s commitment extends beyond course delivery to include leadership development,
credentialing, and systems-level impact. We support innovation through AI-driven learning
pathways, just-in-time training, and retention boosters tailored to learner needs. This proposal not
only strengthens FDA’s current training systems but reimagines the future of food safety
education, delivering high-impact, learner-centered training that protects public health and
advances a unified, performance-ready workforce.

Public health relevance
Project Narrative The National Environmental Health Association (NEHA) proposes to advance the Food and Drug Administration’s Office of Training, Education, and Development (OTED) vision by expanding access to high-quality, competency-based training through scalable course delivery, modernization, and longitudinal evaluation. By also advancing the Partnership for Regulatory Education and Training (PRET), NEHA will strengthen local instructor capacity and reduce disparities in training availability across diverse jurisdictions. NEHA will, in addition, conduct retention studies and apply adaptive learning strategies to ensure lasting knowledge application and continuous workforce development, supporting a future-ready Integrated Food Safety System (IFSS).